Emergent Properties of Complex Systems: From Atoms to Macromolecules; from Humans to Societies

Project Summary (30 lines)
With its revised title “Emergent Properties of Complex Systems: From Atoms to Macromolecules; from
Humans to Societies” this proposal has been broadened by adding data-analysis & simulation on a problem
of grave current concern: namely how an air-borne virus like SARS-2-CoV spread in human population.
Getting involved by accident, I became fascinated with how the numbers of daily cases & deaths group with
time and what is the physical mechanism that make the data follow the Gompertz function.
Michael Levitt, the Principal Investigator has a long career of independent scientific research that started in
1967 when he was one of the first to work in computational biology. His early work set up the conceptual,
theoretical and computational framework for protein and DNA structure refinement, structure analysis and
macromolecular simulations. He makes computer codes available and has been productive, scientifically
rigorous and impactful for half a century. This approaches is continued here by a PI committed to mentoring
young scientists as well as engaging in sustained research-community service and public outreach.
1. Protein Structure Refinement with Deep Equivariant Networks. We propose to use Deep Learning
technique to refine models of proteins. We anticipate that such an approach, combined with the power of
modern neural net architectures and computational performance of hardware will enable efficient sampling
of the protein conformational space near the native state and will systematically provide structures with
accuracy useful for drug development purposes.
2. Functional Dynamics of Ribosome. Our experience with structure curation will lead to a useful computer
package for others. Our work on Ribosome dynamics will provide a model of how peptides such as SecM
can stall the ribosome. Structures sampled from our MD simulations could also be used as potential
targets for drug discovery.
3. Epidemic Analysis, Curve-Fitting and Simulation. Applied to SARS-Cov-2 and COVID-19, we show
that viral spread follows the Gompertz growth function rather than commonly assumed Logistics or
Exponential functions. This means that the population transmitting the infection is not uniform. Network
simulation of viral spread shows that only when the connection network is scale-free does the simulated
epidemic follow the Gompertz function. We will model a physical system with scale-free connectivity using
molecular dynamics to simulate a 2D gas of particles with a wide range of masses. This novel multi-
disciplinary approach may also apply to future respiratory viruses to enable better control of their spread.
Studying biomedically significant systems in collaboration with experimental colleagues will reveal fascinating
details of biology in action. We expect this work will help elucidate the relationship between underlying
structure and function in complex systems, extending from macromolecular machines to human societies.

Public health relevance
Project Narrative (8 lines) With revised title “Emergent Properties of Complex Systems: From Atoms to Macromolecules; from Humans to Societies” this proposal uses data analysis and simulation to show how fundamental interactions lead to complex emergent behavior. Our half a century of experience on how atomic interactions lead to the complex molecular systems key to human health will be applied to protein structure refinement and ribosome function, two long-standing difficult problems. The scope of the work will be broadened to apply the same philosophical approach to a pressing public health problem: how viral diseases spread. Atoms will be replaced by people, atom type by their mobility, infectivity and recovery rate, and the “interatomic forces” by human interactions. Such ‘atomistic’ simulations are expected to reveal how spread can be controlled.